Administrative Core

Administrative Core Abstract:
The PITT-ADRC Administrative Core has functioned for nearly 40 years to
operate a cohesive, coordinated, and effective Alzheimer’s Disease Research Center. The Core functions to
provide central coordination, oversight and leadership to the various core components, Research Education
Component, and Developmental Projects. The Core has also developed a pipeline to collaborate with PITT on
faculty recruitment and retention across a diverse range of expertise, fostering an environment of collaboration
and team science. Another administrative function critical the Core function and overall Center success, is to
liaise with PITT-ADRC internal and external advisors to determine progress and overall direction of the Center.
Finally, the Core provides the infrastructure and oversight to allow for broad data sharing and dissemination of
key research findings to the scientific and lay communities. The Core provides the organizational structure and
leadership for planning and implementation of all activities aimed at the fulfillment of the PITT-ADRC mission
and goals.
The Core monitors budgets to ensure fiscal responsibility and organizes the review and funding process for
the Developmental Projects and the philanthropically funded pilot studies. It monitors all PITT-ADRC research
projects utilizing PITT-ADRC participants or resources including regulatory compliance. Establishment of
outreach efforts to the medically underserved and historically excluded communities are directed and
stimulated by the Core. The Core also oversees participation in multicenter studies, data transfer to NIA
databases, tissue, and DNA samples to NIA repositories, cross-ADRC collaborations, and other national and
international initiatives. Through the establishment of a comprehensive communications system the Core
Leaders, investigators, and staff maintain an integrated, coherent, and multidisciplinary focus.
The goals of the Core are achieved by the Executive Committee, which is comprised of the Director, Co-
Directors, Center Administrators, Core Leads and Co-Leads. It is aided in these tasks by advice of the Internal
and External Advisory Committees. They provide scientific advice on research and operations of the PITT-
ADRC, as well as recommendations for new initiatives.
The Core coordinates a well-established research infrastructure that will serve to the local, national, and
international scientific community. The Core will continue improving the ADRC data collection and distribution
in collaboration with NIA and NACC. To provide infrastructure for broad data sharing, the Core will also partner
across ADRC, scientific, and lay communities. We will provide modernized data sharing infrastructure to
ensure integrity and seamless sharing of data with NACC and other repositories as well as with the entire
ADRD community. Finally, the Core will oversee all aspects of the PITT-ADRC Theme to ensure investigator
engagement, quality data collection, and inclusivity.